Roles of aging and cellular senescence in the development of intracranial aneurysm rupture

Project Summary
Clinical studies have consistently shown a strong association between aging and increased risk for intracranial
aneurysm rupture. Aging has traditionally been considered a non-modifiable risk factor. However, it is
becoming evident that some of the biological changes associated with aging can be modifiable or partially
reversible. Thus, pharmacological therapies targeting age-related biological events may be utilized to prevent
aneurysmal rupture.
Aging induces diverse changes in cellular homeostasis. One of the hallmarks of aging is cellular senescence, a
state of permanent proliferative arrest. Senescent cells secrete pro-inflammatory and tissue remodeling
cytokines collectively called the "Senescence-Associated Secretory Phenotype" (SASP). In addition to aging,
cellular stresses induced by inflammation, reactive oxygen species, mitochondrial dysfunction, and
hemodynamic stresses cause "premature, pathological senescence" in both young and aged individuals. Thus,
we hypothesize that excessive senescent cell burden collectively caused by age-related and premature
senescence may promote aneurysmal rupture through SASP-induced inflammation, tissue remodeling, and
tissue damage. We will test whether the elimination of senescent cells prevents aneurysmal rupture. In
addition, we will identify a rupture-promoting SASP profile using a proteomic approach.
Aim 1 is to test whether aging promotes aneurysm rupture while increasing the total senescent cell burden.
Using a mouse of aneurysm, we will establish the link between aging and the promotion of aneurysm rupture in
both sexes. We will also assess potential sex differences in senescence and their contributions to aneurysm
rupture. Aim 2 is to test whether cellular senescence promotes aneurysm rupture. We utilize pharmacological
and transgene-mediated “senolytic” approaches to establish the causal link between cellular senescence and
aneurysm rupture. We will employ (2a) a prototypical senolytic drug, ABT263 and (2b) transgene-mediated
senolysis of p16-3MR mice. In addition, we will assess the relative contribution between age-related
senescence and stress-induced premature senescence. Aim 3 is to identify rupture-promoting SASP profile
and establish a screening platform for future studies. 3a. By applying proteomics to the cerebral arteries from
Aims 1 and 2, we will identify a rupture-promoting SASP profile. 3b. We will identify the cell type that produces
rupture-promoting SASPs. Using the data from 3a and 3b, we will establish an "in vitro to in vivo" screening
platform for testing existing senolytics and senomorphs. 3c. We will validate the screening platform and key
rupture-promoting SASPs.
This proposal seeks to establish the causal links between aging, senescence, and aneurysmal rupture. The
screening platform developed in this proposal will be used to test existing senolytics and senomorphs for
preventing aneurysmal rupture in future studies.

Public health relevance
Project Narrative Clinical studies have consistently shown a strong association between aging and increased risk for intracranial aneurysmal rupture (i.e., aneurysmal subarachnoid hemorrhage). One of the hallmarks of aging is cellular senescence, a state of permanent proliferative arrest. We will study the mechanisms by which aging and cellular senescence promote aneurysm rupture to develop new therapies that target aging-related biological processes or senescence to prevent aneurysm rupture.